Administrative Core

The Administrative Core will manage, coordinate and evaluate all aspects of the University of Colorado Skin Diseases Research Core Center (UCAMC-SDRC), We will add Xiao-Jing Wang to our leadership team of David Norris, Dennis Roop and Richard Spritz, but will retain most features of the successful Administrative Structure from the first 4 years of funding.

Public health relevance
This proposal will address research areas highly relevant to NIAMS priorities: biology of skin stem cells, regenerative medicine, developmental biology of the skin and appendages, melanocyte biology, keratinocyte differentiation, immune and inflammatory skin diseases, adaptive and innate immunity, identification of the genetic basis of skin disease and development of animal models to study those diseases.